Mid-Career Mentoring Award for Patient-Oriented Research in Aging

PROJECT SUMMARY/ABSTRACT: I, Edward R. Marcantonio, MD, SM, am a board-certified geriatrician and patient-oriented aging researcher, Associate Professor of Medicine at Harvard Medical School (HMS) and Director of Research in the Division of General Medicine and Primary Care at Beth Israel Deaconess Medical Center (BIDMC). The long term objectives of my career are to conduct patient-oriented research (POR) to improve the quality of care and outcomes of hospitalized older adults, and to provide mentoring to new investigators interested in POR in aging. Over the past 16 years, I have built a successful, independent, NIH-funded program of research focused on delirium (acute confusion), a common, morbid and costly condition in hospitalized older adults. I have conducted a series of observational and interventional studies designed to improve diagnosis, target individuals at risk, identify modifiable risk factors, and test intervention strategies to reduce the incidence, severity and duration of delirium. Through these studies, I have gained the knowledge and skills necessary to conduct high quality POR and to mentor new investigators, and have been recognized for my excellence in mentoring with two prestigious awards. In this context, the primary objectives of this K24 Award are: 1. To continue to build a research program around improving the quality and outcomes of care for hospitalized older adults with delirium. This objective will be accomplished through my currently funded studies, including an NIA-funded R01 entitled 3D-CAM: Deriving and validating a 3-Minute Diagnostic Assessment for Delirium, and my new research, a Biomarker Discovery for Delirium project described in this application. Receipt of the K24 will enable me to more effectively leverage these studies and other ongoing work to support the work of trainees, who will in turn expand my research program. 2. To build a mentorship program that will expand POR in aging at BIDMC and HMS, with a focus on delirium and related conditions. This objective will be accomplished through structured, individual mentorship of young investigators with a strong interest in POR. Protected time for mentorship will be provided by the K24 award. 3. To expand my mentorship program to include translational, interdisciplinary work around biomarker discovery for delirium, and biomarker applications to improve risk stratification, diagnosis, and prognostication of older adults with delirium. This objective will be accomplished through my new research project, career development activities, and interdisciplinary collaborations that will be facilitated by receipt of the K24 award. My objectives will be greatly facilitated by the superb academic environment and outstanding institutional support provided by HMS and the BIDMC Divisions of General Medicine and Gerontology.

Public health relevance
PROJECT NARRATIVE: Delirium (acute confusion) complicates over 25% of the more than 12 million hospital stays per year of older adults in the U.S., leading to substantial morbidity, mortality, and cost. The goals of this K24 Award are to conduct patient-oriented research (POR) in the field of delirium, and to train new investigators in POR focused on improving diagnosis, monitoring, and treatment of delirium. The ultimate goal of this Award is to expand research activity and capacity in this critically important area, thereby improving the health of seniors. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Delirium is common among hospitalized older adults, affecting 30-40% of general medical patients (32,33), 25% of elective non-cardiac surgery patients (1), and up to 50% after hip fracture repair, cardiac surgery, and other high risk procedures (2,34). Older adults who develop delirium have worse in-hospital outcomes (34-40), including 2-3 fold more nosocomial complications, and a 2-20 fold increased in-hospital death rate (1,35). These associations remain significant after adjusting for baseline cognitive and functional status, comorbidity, and severity of illness (34-40). Delirium is extremely costly, significantly prolonging acute hospital length of stay, and leading to a 3-fold increased use of inpatient post-acute care (1,35,41). The total incremental one- year cost of delirium is $8 billion in acute care, and over $100 billion in total healthcare costs (42). Despite this compelling evidence, delirium often remains under-diagnosed and poorly managed (43,44). Less than 20% of delirium in the hospital is recognized (45-53) despite improved diagnostic methods such as the Confusion Assessment Method (CAM) (54). Moreover, since the mechanisms of delirium are not well understood (55), no treatments are available that address pathophysiology. We do not know what interventions facilitate delirium resolution, nor which patients are likely to have poor outcomes after delirium or how to prevent them. The overall goal of my research program is to address key barriers to the care of hospitalized older adults with delirium. The aims of my currently funded R01, entitled "3D-CAM: Deriving and validating a 3-minute diagnostic assessment for delirium" are to develop and prospectively validate a short diagnostic tool for delirium. The long term of goal of this research is to integrate routine assessment of delirium into the care of hospitalized older adults, thereby improving diagnosis, monitoring, and prognostication. The goals of my new research, entitled "Biomarker Discovery for Delirium", are to discover and validate plasma biomarkers for delirium. Delirium biomarkers could also lead to improved diagnosis, monitoring, prognostication and the development of targeted therapies (11). This new research is a major project within the five-year program project application "Interdisciplinary Study of Delirium and Its Long Term Outcomes" (PI: Sharon Inouye), which recently received a 2nd percentile score and we anticipate funding over the next several months. In addition to my funded and new research, I am strongly committed to mentorship. If funded, the K24 would come at an optimal time in my career, enabling me to reduce my clinical and administrative commitments, off- load some of my day-to-day research responsibilities, and use my currently funded and new research as a platform for growing my mentorship program in patient-oriented research in aging. My new research will expand my POR mentorship program in aging, combining biomarker discovery with traditional clinical epidemiology to create additional interdisciplinary and translational research opportunities for trainees. In this context, I propose the following Specific Aims for my K24 award: Current Research: To use my currently funded research, in particular the 3D-CAM R01, as a platform to mentor junior investigators in patient-oriented research in aging, with a particular emphasis on improved diagnosis, management, and prognostication of delirium in hospitalized older adults. New Research: To integrate biomarker discovery into a large epidemiological investigation of delirium and its long term outcomes in 500 patients undergoing six types of major non-cardiac surgery being conducted as part of the program project (P01). We will use two state-of-the-art biomarker discovery techniques: 1) simultaneous assessment of multiple inflammatory cytokines using a multiplex analyzer (56); and 2) proteomics using quantitative mass spectrometry (57) in matched samples of surgical patients who do and do not develop delirium. We plan to collect blood from participants at 4 time points: 1) at the time of the baseline study assessment, 2) immediately after surgery in the post-anesthesia care unit, 3) on postoperative day 2, and 4) one-month after surgery. Using these samples, at the end of year 2 we will create a matched longitudinal biomarker discovery sample of 50 surgical participants with delirium and 50 matched surgical participants without delirium. In year 4 of our study we will create an independent matched biomarker validation sample of 100 surgical participants (50 with and without delirium). We have the following Aims: 1. Using the biomarker discovery sample, we will describe a cytokine "signature" for delirium using the Luminex multiplex analyzer system (56) that simultaneously measures 28 plasma cytokines. We will confirm this cytokine signature in the discovery sample and validate it in the biomarker validation sample using ELISA. 2. Using the biomarker discovery sample, we will use quantitative mass spectrometry proteomics (57) to describe a plasma protein "signature" for delirium. We will perform two validations: first, using proteomics in the biomarker validation sample, and then using ELISA in the combined discovery and validation samples. 3. Using the combined discovery and validation samples, we will examine the relationship of the cytokine and protein signatures for delirium with cognitive and functional outcomes up to 18 months after surgery. 4. Using all blood samples from our participants, we will create a bio-repository of genetic material and plasma, a resource for future biomarker discovery studies, including those of my trainees.